Admin-Core-001

The Center for Clinical and Translational Science and Training (CCTST) aims to maximize the impact of
clinical and translational research, in order to improve individual and population health in the Greater Cincinnati
area and across the U.S. The CCTST is a collaboration between the University of Cincinnati (UC), two affiliate
health care institutions [UC Health and Cincinnati Children’s Hospital Medical Center (CCHMC)], and the
broader community – from the local metropolitan area to the CTSA network and academic health centers
around the country. Under CCTST 3.0, the overall governance structure will remain largely intact, as we
continue to benefit from the exceptional leadership team and strong institutional support drawn from our
affiliate institutions. Our robust membership base includes over 4,300 investigators, trainees, and staff from the
CCTST affiliate institutions, and we have assembled a number of councils and committees with advisory,
informational, and stakeholder enfranchisement functions. Through our CCTST Executive Committee, we have
brought together and empowered a diverse leadership team that will work to collectively achieve the following
overarching aims: Aim 1: Engage stakeholders to collaboratively translate research into improved health care
practice and community wellness across the lifespan, using learning health system principles; Aim 2: Develop
a diverse, multidisciplinary workforce to conduct innovative, team-based, community-engaged translational
research and to disseminate and implement findings to improve health outcomes and reduce disparities; and
Aim 3: Optimize the use of biomedical data across the translational research continuum using innovative data
science methods to advance discovery, dissemination, and implementation. Our leadership team will optimize
collaboration across our core functional areas, with our advisory groups, with our affiliate institutions, and
throughout the community. They will also carry out a thorough evaluation program to ensure continuous
improvement and maximum impact of our services, centered around assessment of impact, return on
investment, and value. Under CCTST 3.0, we will continue to maximize quality and efficiency by harmonizing
all services such that the needs of each investigator are met to the limits of our mission, resources, and
abilities.